Immunology of advancing disease among minorities with Multiple Sclerosis

Greater disease severity and a more rapid disease progression is observed in the USA among African Americans (AA) and Hispanics (HSP) with Multiple Sclerosis (MS) compared to Whites with MS. Despite these observations, very little data is available regarding the biological underpinnings resulting in this increased risk of unequivocal advancing disease among AA and HSP with MS even though the incidence of MS disease is growing among AA and HSP populations. Further, there are concerns that AA and HSP with MS are refractory to first-line therapies, which increases the concern that the poor outcomes reported reflect substandard care and treatment.
Our long term goal is to facilitate prevention of neurological deficits in all patients with MS by identifying the mechanism(s) of CNS inflammation contributing to intensified progression and severity of disease. Others have shown that AA and HSP with MS display higher IgG index and synthesis rate, oligoclonal band positivity and an inverse correlation of IgG index with gray matter atrophy. These data support a pronounced role for B cells and their antibody products in the pathobiology of MS in AA and HSP populations.
Our central hypothesis is that the underlying mechanism of unequivocal advancing disease among AA and HSP with MS involves expansion of plasmablasts producing antibodies and/or inflammatory products that cause neuronal toxicity independent of genetic (i.e. ancestral) predispositions. These studies will provide novel mechanistic insights into the role of neuron-reactive plasmablasts in CNS inflammatory events associated with intensified progression and severity of disease in AA and HSP with MS. Our findings will also support future studies to develop diagnostic and predictive tools that inform patient response to treatment and inform clinical course such as relapse of MS or progression to MS in AA and HSP populations.

Public health relevance
NARRATIVE Minorities with MS face increased disease severity in comparison to whites with MS, possibly due to the differences in the immune responses between the populations, making it important to understand the contribution of the immune response to disease severity in Minorities with MS. We have observed that plasmablasts are expanded in Minorities with MS in comparison to whites with MS. In this project, we will test whether these expanded plasmablasts make antibody that binds to neurons and makes disease worse using a mouse model.